Novel proteasome inhibitors targeting both beta5 and beta2 subunits for treatment of triple negative breast cancer

Project Summary/Abstract
Proteasome inhibitor (PI) drugs turned untreatable multiple myeloma treatable, significantly improve the
quality of life for multiple myeloma patients. There are three FDA-approved PI drugs. In additional to
multiple myeloma (MM), PI drugs are also approved to treat mantle cell lymphoma (MCL), amyloid light
chain (AL) amyloidosis and Waldenström macroglobulinemia, the latter two are noncurable rare
disorders related to plasma cells. Nevertheless, resistance inevitably occurs. All three drugs have
serious toxicities. A high percentage of patients suffer from neuropathy, a debilitating adverse effect
from two peptide boronate based PI drugs, bortezomib and ixazomib. Another PI drug carfilzomib also
has cardiovascular and renal toxicity. Notably, none of the PI drugs showed little clinical benefits in
treating patients with solid tumors in numerous clinical trials. Studies have shown that upon treatment
with PIs, a transcription factor NRF1 will be activated to express more proteasomes that renders PI
drugs less or non-effective. Recent studies show that when chymotryptic β5 and tryptic β2 of the
proteasomes are simultaneously inhibited, NRF1, instead of activation, forms aggregated, disarming the
ability of tumor cells to resist apoptotic stress induced from proteasome inhibition. Because of the
striking difference between the “chymotryptic” proteolytic preference of β5 to cleave after hydrophobic
residues and the “tryptic” preference of β2 to cleave after basic residues, it is challenging to develop
inhibitors that can target both β2 and β5 with similar potency. Besides, such β5β2 targeting inhibitors
would also have to spare the “acidic” β1 active subunit to avoid nonspecific cytotoxicity. No such
inhibitors have been reported in peptide boronate and peptide epoxyketone classes. There are three
known β5β2-inhibitors in other classes, all of them irreversible, carrying unpredictable toxicities. We
have now designed and characterized a group of macrocyclic peptide boronates that simultaneously
inhibit β5 and β2, but not β1. These compounds elicit markedly less NRF1 activation in triple negative
breast cancer cells (TNBC) than BTZ. We now aim to continue our team approach to advance the
structure-guided development of β5β2 inhibitors for cancer treatment by improving their specificity and
pharmaceutical properties and evaluate their in vitro anticancer activity and in vivo efficacy in animal
models of TNBC. In Aim 1 of this proposal, we will conduct structure-guided lead optimization to improve
β5β2-inhibitors’ potency, specificity and pharmacokinetic properties. In Aim 2, we will test β5β2-
inhibitors' cytotoxicity against breast cancer line cells. Aim 3 will test the efficacy of β5β2-inhibitors in in
animal models of TNBC.

Public health relevance
Project Narrative Proteasome inhibitor drugs revolutionized the treatment of multiple myeloma and mantle cell lymphoma. However, the current proteasome inhibitor drugs have little efficacy in solid tumor treatment. We propose to develop novel proteasome inhibitor drugs that overcome the shortcomings and expand the anticancer spectrum of the current proteasome inhibitor drugs from hematological malignancies to solid tumors.